CaRE2 NCI Diversity Supplement

Contact PD/PI: WILKIE, DIANA J
SUMMARY – OVERALL COMPONENT
The Florida-California Cancer Research, Education & Engagement (CaRE2) Health Equity is proposed by
the University of Florida (UF), Florida A&M University (FAMU) and the University of Southern California-Norris
Comprehensive Cancer Center (USC-NCCC) to eliminate cancer health disparities in Florida, California and
nationally. The long term goals of the CaRE2 center are to reduce cancer disparities in Blacks and Latinos, to
train and increase the pool of underrepresented Black and Latino scientists conducting health disparity research,
to increase research capacity at FAMU, and to increase cancer disparity research at UF and USC-NCCC. The
bi-coastal location offers access to uniquely diverse populations of Blacks and Latinos, facilitating in an
unprecedented way, the study of cancer disparities in these incredibly heterogeneous populations. Specifically,
the center will focus on studying relevant issues and serving the needs of: (1) Black subpopulations, including
American-born, African-born and Caribbean-born Blacks; and (2) Latino subpopulations including Mexican-
Americans, Caribbean Latinos, Central and South Americans. This triad brings together investigators and
institutions in the two US states that currently have the highest cancer incidence and mortality. The main scientific
focus of the center is translational disparities research among heterogeneous minority populations focusing on
cancers known for high mortality. We propose to coalesce expertise, infrastructure and share resources in
support of 6 innovative translational research projects focused on understanding the biological basis of
disparities in Black and Latino populations, capturing the wide heterogeneity within these two groups, with two
foundational projects focusing on pancreas cancer (one full, one pilot) and one full project focusing on prostate
cancer (Aim 1). Under the leadership of the Research Education Core, we propose to train 100 Black and Latino
investigators, including students and early stage investigators (ESI), in translational cancer health disparity
research (Aim 2). Existing community partnerships in the Outreach Core will be leveraged to disseminate findings
in the Black and Latino community, educate about pancreas and prostate cancer, and improve participation in
biomedical research (Aim 3). Finally, the Planning and Evaluation Core will implement a systematic planning and
evaluation plan to improve Center effectiveness using innovative strategies (Aim 4). All research projects will be
facilitated and enriched by resources and approaches provided by the Tissue Modeling Core and Bioinformatics,
Statistical and Methodological Core. All CaRE2 Center’s activities will be centralized and overseen by the
Administrative Core. The FAMU-UF-USC partnership is ideally suited to achieve these aims. Both UF and FAMU
have worked closely together addressing cancer disparities in Florida Blacks for the last 4 years. USC-NCCC
provides complementary and synergistic expertise in cancer disparities research, research training for the Latino
population, and expertise in developing culturally-sensitive tools to reduce cancer disparities among Latinos.
Project Summary/Abstract Page 188

Public health relevance
Contact PD/PI: WILKIE, DIANA J PROJECT NARRATIVE – OVERALL COMPONENT The long term goals of the CaRE2 center are to reduce cancer disparities in Black/African American and Hispanic/Latinx individuals, to train and increase the pool of 120 underrepresented Black/African American and Hispanic/Latinx scientists conducting health disparity research, to increase research capacity at an HBCU (FAMU), and to increase cancer disparity research at UF and USC-NCCC. The proposed two full projects and pilot project include investigators from the three institutions and will leverage on specimens collected across the partnership from Black/African American and Hispanic/Latinx, representing a wide range of subpopulations within these minority groups. Thus, our studies will reveal unprecedented findings about these two understudied minority populations, will be instrumental in transferring cutting edge and innovative technologies to FAMU, and will expand in a significant way the research focus at UF and USC-NCCC to address cancer health disparities in pancreas and lung cancers. Project Narrative Page 189